Linking temporal patterns of modifiable behaviors to weight loss outcomes

PROJECT SUMMARY & ABSTRACT
This K01 Career Development Award addresses the significance of three key modifiable behaviors (physical
activity, energy intake, and sleep) for weight loss and weight loss maintenance. Previous investigations have
identified that the absolute amounts of physical activity (200-300 min/wk) and energy intake (~1800 kcal/day)
are associated with weight loss and weight loss maintenance. In addition to physical activity and energy intake,
epidemiological and controlled laboratory studies suggest that sleep is important for bodyweight regulation;
however, the importance of sleep during a behavioral weight loss intervention has not yet been evaluated. This
study will be one of the first studies to evaluate if indices of sleep are associated with enhanced adherence to
physical activity and energy intake prescriptions during a weight loss intervention and greater weight loss.
Findings from this study may lead to more comprehensive behavioral weight loss therapies focusing on sleep
behavior as well as physical activity and eating behaviors. In addition to the absolute amounts of physical activity,
energy intake, and sleep, emerging evidence suggests that temporal patterns (timing across the 24h day and
consistency day-to-day) of these behaviors influence weight loss outcomes. The global hypothesis is of this
application is that earlier timing of these behaviors (e.g. morning physical activity, eating more calories earlier in
the day, earlier bed/ early rise times) and consistency (day-to-day and weekday-to-weekend) will be associated
with greater weight loss, better adherence to the diet and physical activity prescriptions during a behavioral
weight loss intervention, and weight loss maintenance. Identifying temporal patterns of these behaviors that are
associated with enhanced adherence and greater weight loss will aid in the development of novel, translatable,
and effective behavioral strategies for long-term weight loss. The proposed research plan will advance the career
of the applicant, Seth A. Creasy, PhD facilitating his transition to independent investigator status over the five
years of K01 support. A team of highly productive, multidisciplinary scientists (Drs. Edward Melanson, Victoria
Catenacci, Nichole Carlson, Celine Vetter, Valerie Myers) will collectively serve as mentors to Dr. Creasy during
the proposed research at the University of Colorado – Anschutz Medical Campus. This team of mentors has the
expertise to train Dr. Creasy in physical activity assessment methods, doubly labeled water theory and
methodology, assessing energy intake, novel metrics for quantifying times-series data, and
developing/conducting large, clinical weight loss interventions. In sum, the proposed training and expert
mentoring team will provide Dr. Creasy with the skillset and preliminary data necessary to compete for R01
funding, and this award will serve as a catalyst making Dr. Creasy a leader in the field of lifestyle interventions
for treating and preventing obesity.

Public health relevance
PROJECT NARRATIVE Overweight and obesity are significant public health problems in the US and have been linked to numerous chronic diseases including cardiovascular disease, type 2 diabetes, and some forms of cancer. Increased physical activity, reduced caloric intake, and getting adequate sleep have been identified as important behaviors for improving long-term weight loss. In addition to the absolute quantities of these behaviors, the timing and pattern of behavior may be very important for adherence to a lifestyle intervention, weight loss, and weight loss maintenance. Data from this study will identify whether the timing of these behaviors (e.g. morning vs. evening) or the consistency of these behaviors (e.g. day-to-day, weekday-to-weekend) is important for weight loss outcomes. These results will provide important information that will influence future weight loss intervention strategies and public health recommendations.